Pan-cancer Analysis of Convergent Immunoglobulins from Tumor-infiltrating B Cells

Project Summary
Tumor infiltrating B cells (TIL-B) express B cell receptors (BCR) and antibodies (Abs) that can have a role in
antitumor function. What tumor antigens they target can give insight into anti-tumor immune function and
potentially leveraged for therapeutic strategies. Public tumor RNA-seq databases such as the TCGA, represent
a wide and deep data source that include TIL-B BCRs. Our analysis of these datasets reveals the surprising
finding of BCRs with the same V, J and complementarity-determining region 3 (CDR3) shared across patients.
The occurrence of this phenomena by random chance is extremely rare (as low as one in 10 trillion) and therefore
suggests a convergent response shared in patient tumor types. Although BCR repertoire has been analyzed in
small groups of patients, a wide BCR analysis within and across tumor types has not been done. Analyzing
convergent BCRs could inform what common antigen targets the immune system is focusing on. The bulk of
tumor sequencing data exists as NGS RNA-seq. A challenge for reconstructing a BCR is matching the
immunoglobulin heavy and light chains. To accomplish this, we have developed a comprehensive algorithm
based on our Frequency Inference Model (FIM) to predict the paired heavy and light chains from sequencing
datasets. We propose to refine our sequence analysis by leveraging machine learning algorithms to inform our
ability to clone, produce and characterize Abs shared across patient tumor samples. This proposal will
characterize antibodies reconstructed from RNA-seq datasets and test their tumor and antigen recognition
characteristics. Abs will be tested for anti-tumor potential and antigen identification will be done on a small cohort
with the following aims.
Aim 1: Analyze immunoglobulins from different cancer types in TCGA. Convergent immunoglobulins will
be identified, and matching chains identified by leveraging the deep learning algorithms.
Aim 2: Produce shared Abs using the MDACC Recombinant Antibody Production Platform based on the
computationally derived immunoglobulins. The reactivity to cell lines and tumor samples will be analyzed.
Aim 3: Elucidate targets of TIL-Bs and their cognate BCRs and evaluate the anti-tumor function the
antibodies. A pipeline to identify antigen epitopes will be used. The anti-tumor function of the antibodies will be
assessed.
With the completion of these aims we will have a proof-of-concept that our pipeline can recapitulate
shared BCRs and assess tumor targeting potential. This platform would enable identifying shared patient antigen
response that could be potentially leveraged to develop therapeutic targeting strategies.

Public health relevance
Project Narrative Characterization of TIL-B BCR recognition properties are scientifically and therapeutically important because recent cutting-edge studies have shown that TIL-B cells and tertiary lymphoid structures promote immunotherapeutic response. With the leverage of the computational reconstruction of antibodies from tumor sequencing databases and the advanced machine learning algorithms, we will be able to identify candidates for tumor related immunoglobulins, which will be further evaluated by our high throughput experimental pipelines for functional characterization of tumor suppression and antigen identification. The scope and impact of these studies are consistent with the missions of the National Cancer Institute.